TRAINING OF BIOMEDICAL SCIENTISTS IN MASS SPECTROMETRY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We have instructed a number of individual scientists and students in detailed advanced mass spectrometry techniques. These are often one-on-one training sessions that can span a period of one day to several months.